Clonable Nanoparticles

PROJECT SUMMARY
The objective of this proposal is to address the contrast problem in images formed by X-Ray, electron, or other
scattering based illumination modalities. Briefly, images are made by contrast. In other words, we only see (or
acquire information) on things that are distinguishable from their background. In all forms of biological imaging,
many things are visible, yet many other things remain camouflaged or indistinguishable from the background.
For instance, in an X-ray, it's easy to see bones, but not so easy to see muscles, fat or skin. This is also true in
microscopic images, where it's often easy to see the edges of cells, but much harder to see the details inside
cells. Green Fluorescent Protein and related fluorescent proteins complement small molecule stains and dyes
to essentially solve the contrast problem in optical imaging. For imaging based on X-rays or electrons,
however, there are no clonable contrast agents.
Clonable contrast (a GFP homolog) in X-Ray or electron-based imaging could be understood as a `clonable
nanoparticle.' Such a nanoparticle would scatter incident radiation and would be made by a protein that can be
genetically fused to other proteins of interest. Three discrete chemical activities are needed for such a clonable
nanoparticle: (1) conversion of bioavailable inorganic ions to insoluble nanoparticulate form; (2) maintenance of
the nanoparticle at the protein that synthesizes it; (3) size control of the nanoparticle, where 5nm diameter is
suggested as an ideal size. We recently isolated a metalloid reductase that appears to partially fulfill each of
these chemical requirements. We propose to build on this finding to create a pipeline that will produce many
clonable nanoparticles of distinct size, shape or elemental composition. The most broadly useful clonable
nanoparticles will simultaneously incorporate X-ray/electron scattering, magnetism and fluorescence. Such
nanoparticles could serve as `universal clonable contrast agents' functioning in optical, MRI, X-Ray and
electron imaging. Such a tool would greatly facilitate integrative and/or correlative multiscale bioimaging,
integrating information from multiple imaging modalities.
The proposed work will proceed in three specific aims. Candidate clonable nanoparticles will be identified and
refined in Aims 1a and 1b. Refinement of our existing clonable nanoparticle candidate will proceed through
directed evolution methods of saturation mutagenesis, DNA shuffling, and random mutagenesis. Isolation of
additional variants and novel enzymes will begin with field samples collected in areas with persistent
environmental metal contamination. Candidate clonable nanoparticles will be assessed in in vitro, in situ and in
vivo within Aim 2 using 3 model and experimental systems we have identified to assess portability across
species and suitability in in vivo, in situ, and in vitro chemical environments.

Public health relevance
PROJECT NARRATIVE The public health significance of this enabling technology is that imaging technology is fundamental to biomedical knowledge and progress. Our tools will enhance structural information in normal and diseased tissues, cells and molecules. Our model systems may allow novel findings in synaptic transmission, viral pathogenesis, and bacterial cell division.